Linking brain and behavior across and around the visual field

Project Summary
Vision at the center of gaze (fovea) has high sensitivity and resolution, facilitating good performance in many
tasks. But performance worsens with increasing distance from fovea–eccentricity. At any given eccentricity
stimuli can fall anywhere along the circle –polar angle. Both eccentricity and polar angle have pronounced effects
on perception in human adults. These factors present an ideal opportunity for establishing tight quantitative links
between behavior and neural representations of visual information. Our long-term goal is to understand how
visual performance varies across the visual field, to develop a theory of spatial vision that includes the neural and
computational mechanisms underlying performance variation with eccentricity, polar angle and individuals. Such
a theory will be applicable to basic and translational research in perceptual and cognitive neuroscience. We
propose to investigate whether and how neural and computational factors distinctly limit discriminability across
observers, eccentricity and polar angle. Our overall hypothesis is that variability in cortical magnification limits
discriminability as a function of eccentricity, polar angle and observer, and that these effects are mediated by
different combinations of noise, efficiency and sensory tuning. The proposed psychophysical [Aim 1] and
neuroimaging [Aim 2] measures will characterize internal/neural noise and sensory/neural tuning across
eccentricity and around polar angle, and will constrain a computational observer model of contrast sensitivity and
acuity tasks [Aim 3].
In addition to advancing our knowledge of visual perception and cognitive neuroscience, the proposed research
will enable us to make predictions about human performance. The characterization of eccentricity and polar
angle has significant implications for ergonomic and human factors applications as well as for public health. For
example, it is of critical importance for user-interfaces that present information at different locations of the visual
field. We can extend our knowledge to real-world displays, such as navigation and cockpit alerting systems,
control panel layouts in cars, computer-aided detection systems, and software for presenting radiological images.
Furthermore, the gained knowledge can aid the design of artificial image recognition systems. In addition,
understanding the underlying neural and computational mechanisms of performance differences across the
visual field will improve our models of visual dysfunction (e.g., macular degeneration, retinitis pigmentosa), as
well as the diagnosis of these disorders.

Public health relevance
Project Narrative We have systematically investigated how visual perception –discriminability– varies across the visual field, along eccentricity and across polar angle. Here, we propose to investigate how and why these differences come about; i.e., the neural and computational mechanisms underlying the differential effects across eccentricity and polar angle. These results will establish normative data sets on adults’ perception and neuroimaging as a function of stimulus location in the visual field, enabling comparison with patient populations (e.g., ADHD and autism), and advance our knowledge of neural and computational mechanisms responsible for visual perception.